Role of probiotic Lactobacillus reuteri in orchestrating systemic anti-tumor immunity

Project Summary
The gut microbiome exerts a profound impact on systemic immunity in health and in complex diseases, such
as cancer. Numerous studies highlighted the robust anti-carcinogenic ability of the gut microbiome to regulate
extra-intestinal (systemic) anti-tumor immunity. Cytotoxic interferon-g producing CD8 T cells (Tc1 cells) play a
central role in mediating anti-tumor immunity by potently killing tumor cells and affecting immune checkpoint
blockade therapies. Bacterial supplements (probiotics) have been used to promote health for more than a
century and are gaining traction as a crucial component in successful cancer immunotherapy in mice and
humans. Yet, the underlying mechanisms how probiotics orchestrate systemic anti-tumor immunity and
modulate cancer immunotherapy outcome remain incompletely understood. Lactobacillus reuteri (L. reuteri) is
one of the most frequently used probiotics and plays a beneficial role in colon cancer. Yet, the role of L. reuteri
in modulating systemic anti-tumor Tc1 immunity remains undefined. The gut microbiota plays a fundamental
role in the maintenance of intestinal barrier integrity and disruption of the gut microbial community (dysbiosis)
constitutes a major risk factor for several forms of intestinal and non-intestinal cancers. Moreover, intestinal
barrier dysfunction and gut bacterial translocation are associated with complex inflammatory diseases
including cancer. We recently showed that gut bacterial translocation resulting from microbiota-mediated
intestinal barrier dysfunction drives preleukemic myeloid malignancy in a mouse model of myeloid cancer.
Microbial signals were identified in intestinal as well as systemic tumors, which serve both pro- and anti-
tumorigenic functions. However, the presence of viable gut bacteria in systemic tumors and the underlying
mechanisms how tumor intrinsic microbes affect tumor immunity remain ill defined. Our preliminary data
suggest that orally gavaged L. reuteri drives systemic Tc1 cell immunity in melanoma tumor bearing mice and
is associated with transient dissemination of viable L. reuteri from the intestine to secondary lymphoid organs
and melanoma tumors. Moreover, we have preliminary indications that melanoma tumor-formation induces gut
barrier dysfunction, which suggests a possible mechanism how orally gavaged L. reuteri can reach gut-distal
melanoma tumors. Based on well documented findings of the systemic impact of gut microbes during
melanoma, together with our preliminary data, our overarching hypothesis is that the probiotic L. reuteri
mediates systemic anti-tumor Tc1 cell immunity and facilitates cancer immunotherapy in melanoma (AIM 1) by
translocation of viable L. reuteri from the gut to gut-distal melanoma tumors (AIM 2). We will test this
hypothesis and dissect the underlying mechanisms how L. reuteri modulates anti-cancer immunity and will
define the mechanisms how L. reuteri gains access to gut-distal tumors. The long-term goal of this proposal is
to provide rational approaches to control systemic tumor immunity by modulating the gut microbiota during
cancer.

Public health relevance
Project Narrative Gut probiotic-based cancer therapeutics have recently gained traction in mediating protective anti-tumor immune responses against gut-distal cancers, such as melanoma. A key barrier to improve probiotic-mediated cancer therapeutics is the lack of well-controlled models and the gap in knowledge whether and how viable gut commensal bacteria reach systemic tumors and thereby modulate systemic anti-tumor immunity. Here we will dissect, in a well-controlled model, the mechanisms how gut probiotics gain access to gut-distal tumors and how tumor-intrinsic probiotics unleash anti-tumor immune responses and boost cancer immunotherapy efficacy - if successful, this proposal will unlock the next wave of microbial-based precision cancer therapeutics.